Immunomics Research Core

IMMUNOMICS AND EPIGENOMICS CORE
PROJECT SUMMARY/ABSTRACT
The Immunomics and Epigenomics Core (IEC) is an essential component of the overall program that will
centralize the execution of a number of assays that will enable the characterization of immune responses. The
overall proposal aims to understand epigenetic changes in patients infected by methicillin-resistant
Staphylococcus aureus (MRSA) or Candida albicans Candidemia (CAC) and the immunologic functions shaping
antibiotic-persistent from resolving outcomes. The IEC Core will provide skilled technical and scientific expertise
to enable the PIs to achieve their research goals by carrying out the following assays. We will characterize the
genetics and epigenetics of MRSA and CAC isolated from patient samples from long reads. Using PacBio
circular consensus sequences we will reconstruct the genomes of SA and Candida isolated derived from patient
samples, derive genomes and epigenomes of these microbes and related the data to patient outcomes. We will
profile transcriptomes and epigenomes from short read data. This will include the generation of whole genome
bisulfite sequencing libraries in order to characterize the cell types and their abundance in blood and plasma
DNA samples. Chromatin accessibility will be profiled using ATC-seq. Protein-DNA interaction will also be
profiled using CUT&Run protocols. Finally, we will also characterize innate and adaptive immune responses in
CAC and MRSA patient samples and the phenotype and function of PAMP-stimulated macrophages. The Core
has validated standardized cell cultures, immunophenotyping panels, multiplex Luminex, ultrasensitive Simoa
assay to support the research of the Projects. We will be responsible for performing these assays, interpreting
the data and working with the Bioinformatic and Data Management (BDM) Core to transfer the data and the
Computational (CPM) Core for further analysis.

Public health relevance
IMMUNOMIC AND EPIGENOMICS CORE (IEC) PROJECT NARRATIVE Candida albicans candidemia (CAC) is the most common invasive fungal species in hospital settings worldwide. Similarly, methicillin-resistant strains of Staphylococcus aureus (MRSA) can cause invasive and life-threatening infections despite treatment with standard anti-infective therapies. The proposal aims to understand the epigenetic changes in patients infected by MRSA or CAC and the immunologic functions shaping antibiotic- persistent from resolving outcomes. The IEP will provide technical and scientific support in designing and implementing the assays to measure epigenomic and transcriptomic profiles along with immune cells in patients infected by MRSA or CAC.